ICorps- A Numerical Platform for Microbubble Enhanced Sonothrombolysis

 Executive Summary of Predicate SBIR or STTR Phase I Grant and Team
The ultimate objective of the parent SBIR Phase I award that started on Sep. 17, 2024 is to develop a
numerical platform which can serve as a research tool during therapy discovery and a treatment planning
system (TPS) during pre-operation planning in clinic, to significantly accelerate the clinical deployment of
microbubble-augmented focused ultrasound (MBaFUS) for non- or minimally invasive thrombolysis.
Sonothrombolysis has been successfully demonstrated in the lab of our NCSU partners to present both
improved efficacy and enhanced safety over conventional treatment methods for thrombosis, which is a
leading cause of death and disability in the United States. However, due to the complex multiple inter-
coupled mechanisms involving MB dynamics, viscoelastic structure dynamics, MB-flow and MB cloud-
blood clot interactions, the physics of MBaFUS for thrombolysis is not well understood yet, thus finding
optimized treatment parameters for a patient-specific condition is difficult. This poses a major barrier to
effective clinical applications and calls for a powerful TPS of sonothrombolysis.
During the 1st week of project kickoff and execution, we realized a) the risks of project management due to
the interdependency of major tasks; and b) the difficulties to conduct sufficient experiments due to the
budget limit of Phase I; Also there’re c) potential pitfalls of TPS design due to the lack of expertise and
resources for a deep understanding of customer needs.
To address a), the main tasks are decomposed into sub-tasks which are able to be conducted in parallel
among different subgroups. For example, while the structure subgroup is working on the modeling and
coding of clot structure dynamics, the MB subgroup has started the parametric study of MB cloud
interacting with and resulting stress on a rigid structure, which reveals that a spherical MB cloud leads to
much more disruptive power than a cylindrical MB cloud. This trend will be validated first in experiments
and then used to greatly narrow down the experimental conditions, i.e. to overcome not only a) but also b).
Finally, concerning c), we appreciate the opportunities to work with the Industry Expert (IE) through I-
Corps program which will result in necessary adjustments to our development roadmap to make it product-
oriented, rather than technology-driven. Therefore, by leveraging the I-Corps discoveries, the completion
of the parent SBIR Phase I will not only successfully reach the objective of proof of concept, but also lay a
solid foundation of commercialization plan for the potential Phase II and its following full
commercialization. During the parent Phase I, the specific aims bellow will be achieved:
Aim 1: Enable TPS-MBaFUS to predict structure dynamics, such as blood clot surface morphology and
clot rupture in the MB cloud-enhanced acoustic field, by developing and incorporating, in an Implicit Fluid-
Structure Interaction (IFSI) mode, constitutive models for mixture materials involving tissues and blood
clots, along with a two-way coupled Lagrangian MB modeling.
Aim 2: Conduct well-controlled and high-quality experiments (in vitro in Phase I and in vivo in Phase II)
to validate code predictions, such as MB cavitation and induced flow, clot morphology, MB cloud motion,
and clot lysis rate under various MB, ultrasound, and clot conditions.
Aim 3: An effective, productive and practical commercialization plan for Phase II application
Our proposed I-Corps team will include the following three members, who are all committed to the time
requirements of the program. Member Name Role William Plishker, PhD
 C-Level Corporate Officer (CEO): Chao-Tsung Hsiao, PhD
 Technical Lead (TL): Jingsen Ma, PhD
 Industry Expert: Bei Ma, MS

Public health relevance
Success of this research will help in developing a better understanding of the complex phenomena of microbubble enhanced sonothrombolysis. The developed software, having both proven accuracy and efficiency, will be marketed as a research platform for fundamental studies, a design tool for therapy planning and to decrease the time required for FDA approval of new microbubble enhanced ultrasound based therapies.